Role of Mitochondria in the Regulation of Iron metabolism by Alcohol

[unreadable] DESCRIPTION (provided by applicant): Mitochondria are critical in iron metabolism and play a role in alcohol-induced liver injury. Alcohol alters mitochondrial function and leads to oxidative stress. We have demonstrated that alcohol-induced oxidative stress down-regulates hepcidin transcription without causing changes in liver histology or an increase in triglycerides. Hepcidin is a circulatory peptide synthesized in the liver. It plays a central role in iron homeostasis by regulating both intestinal and reticulo-endothelial iron transport. Accordingly, alcohol-treated animals exhibited an increase in the expression of iron transporters in the duodenum and the iron storage protein, ferritin in the liver. Alcohol also rendered hepcidin synthesis in the liver insensitive to body iron levels. It is noteworthy, that hepcidin protects the body from iron overload by inhibiting iron transport. Thus, alcohol may compromise this protective mechanism of hepcidin, which may have implications for alcoholic liver disease (ALD). Of note, ALD patients and animal models of ALD display iron overload but the underlying mechanisms are unclear. Our findings suggest that the deregulation of hepcidin synthesis in the liver may be one of the underlying mechanisms of iron overload observed in ALD. Treatment with antioxidants abolished the effect of alcohol on hepcidin expression. Multiple pathways play a role in alcohol-induced oxidative stress, including activation of Kupffer cells, CYP2E1 enzyme and changes to mitochondrial function. Our preliminary results exclude a role for Kupffer cells, TNF alpha cytokine and CYP2E1 in the regulation of hepcidin expression by alcohol-mediated oxidative stress in the liver. Mitochondria also are involved in alcohol-mediated oxidative stress. Alcohol induces lesions in the proteins of the electron transport chain, and reduces ATP/ADP translocation and ATP synthesis in the mitochondria. Our preliminary results suggest a role for mitochondria in the regulation of hepcidin expression. Inhibition of DNA and protein synthesis in the mitochondria caused a significant decrease in hepcidin expression in plain HepG2 hepatoma cells. Mitochondria play a key role in apoptosis and alcohol-mediated changes in mitochondria induce apoptotic stimuli. However, the role of apoptosis in the regulation of hepcidin expression is unknown. Our preliminary findings demonstrate that Fas-mediated apoptosis down-regulates hepcidin expression in the liver. The objective of this application is to identify the molecular mechanisms whereby mitochondria regulate liver hepcidin expression and iron metabolism by alcohol. Our central hypothesis is that ethanol-induced modifications of mitochondrial structure and function play a key role in the regulation of hepcidin transcription by alcohol. We will employ transgenic mouse models deficient in mitochondrial antioxidant enzymes, adenine nucleotide transport, cytochrome c oxidase activity or the dimerization of hypoxia-inducible transcription factors to study the regulation of hepcidin transcription by alcohol-mediated oxidative stress. The knowledge obtained from these studies, characterizing the pivotal role of mitochondria, will enable us to determine the mechanisms of liver injury caused by iron and alcohol in patients with ALD. [unreadable] [unreadable] [unreadable]